ISES 2021 Annual Virtual Conference

Abstract The International Society of Exposure Science (ISES) is the premier international society devoted to bringing the full value of exposure science to research and decision-making to improve human health and the environment. This filled an important gap in environmental health when the society began 31 years ago, and continues to fill that gap. As is often expressed, “without exposure, there is no risk; we need to understand pathways and quantities of exposure to environmental contaminants”. This conference represents the most prominent and comprehensive gathering of environmental exposure scientists and environmental health professionals from academia, government, and organizations from around the world, reflecting the interdisciplinary nature of the field. Recognizing that engagement with diverse stakeholders is key to effective environmental exposure research the 2021 virtual conference theme is Multisector Engagement for Addressing Emerging Environmental Exposures. Meeting themes include: disparities in environmental exposure and health, emerging environmental exposures, climate change, disaster response research, citizen science and community- engaged research, risk communication, statistical methods in exposure science, novel technology/sensors in exposure research, translational research and use of “big data” in exposure science. The 31th ISES annual conference will be held on a well-recognized virtual platform, and will continue the successful of previous meetings, which typically draw between 500 to 700 participants principally from North America, Europe and Asia. The meeting offers three and a half days of cross-disciplinary presentation and discussion of new research and methods of international, national, and regional significance and facilitates the exchange of information and ideas among exposure science and environmental health scientists. The meeting is also an important venue for education, training, and promotion of junior investigators and investigators from developing countries. This proposal will support the virtual platform, engagement of attendees, and registration scholarships for student or new researchers, or those from a developing country or from an under-represented group in order to enhance member diversity, promote the global development of exposure science, and foster collaborations and information exchange both nationally and internationally.

Public health relevance
Narrative The International Society of Exposure Science (ISES) is the premier international society devoted to bringing the full value of exposure science to research and decision-making to improve human health and the environment. This conference represents the most prominent and comprehensive gathering of environmental exposure scientists and environmental health professionals from academia, government, and organizations from around the world, reflecting the interdisciplinary nature of the field.